UAB NORC Core A - Administrative Core

UAB’s Nutrition Obesity Research Center (NORC) has as its long-range mission to reduce the rates of obesity
and improve human health and well-being by advancing knowledge and developing innovative solutions for
nutrition and obesity through collaborative and interdisciplinary research. We do this by supporting and growing
an investigator base of active, funded nutrition and obesity researchers at our institution and facilitating their
ability to conduct the most rigorous and insightful research possible. The Administrative Core serves to convene
this base of research investigators, to help to grow it by recruiting new investigators into the field of nutrition and
obesity from both within and beyond UAB, and to train the next generation of nutrition and obesity research
scientists. We also support the scientific community interested in nutrition and obesity research beyond the walls
of our institution through our Enrichment Program, including a formal program of national short courses and other
offerings supported by additional funds raised beyond those of our NIDDK NORC P30.
The Administrative Core takes responsibility for the careful management of all elements of the NORC, including
oversight of the cores; interactions with and growth of the membership; announcement, selection, and
administration of the Pilot and Feasibility grants; implementation of our training and education programs;
fostering growth with our clinical element; strengthening communications with NIH and UAB’s administration;
facilitating interactions with other NORCs; continually updating the NORC’s website; fiscal management;
convening, soliciting, and adapting to feedback from the NORC internal and external advisory committees; and
finally, ensuring the timely execution of all administrative and regulatory obligations.
The Administrative Core works diligently and proactively to not only meet the objectives above but create and
foster the conditions that allow our investigators to pursue their scientific ideas with maximal efficiency, ease,
and rigor, while also inspiring our current and future investigators to conduct ever more creative and impactful
research on nutrition and obesity.